SICKLE CELL ANEMIA--THE INTRACELLULAR POLYMERIZATION OF HEMOGLOBIN S

The extent of intracellular polymerization of hemoglobin S is primarily determined by oxygen saturation, hemoglobin concentration and hemoglobin composition. We have examined the filterability of sickle erythrocytes to determine whether sufficient sickle hemoglobin polymer forms at arterial oxygen saturation to adversely affect cell deformability. Progressive reduction of oxygen tension within the arterial range caused a sudden loss of filterability of sickle erythrocytes through 5 micron diameter pores at a critical p02 which correlated significantly with the polymerization tendency for each patient. This loss of filterability was reversible upon reoxygenation and occurred at a higher p02 than did morphological sickling. Impairment of erythrocyte filterability at high oxygen saturation suggests that small changes in oxygen saturation within the arterial circulation cause rheological impairment of sickle cells. It has been appreciated that fetal hemoglobin has a specific "sparing" effect in inhibiting polymerization of sickle hemoglobin, however, the exact amounts of fetal hemoglobin necessary to ameliorate the various manifestations of the sickle cell syndromes have been uncertain. Epidemiological analyses of sickle cell disease severity and studies of the biophysics of intracellular polymerization were used to estimate potential clinical benefit of variou levels of fetal hemoglobin for use as guideposts for therapeutic goals in studies designed to increase fetal hemoglobin levels in sickle cell disease. Erythrocytes containing hemoglobin Setif can undergo pseudosickling in the laboratory when incubated under select buffer conditions. Corresponding aggregation of hemoglobin lysate from these erythrocytes was detected when incubated in phosphate buffered saline at either 290 m0sm or 459 m0sm. However, changing buffer conditions reversed the hemoglobin aggregation. Detailed studies of hemoglobin Setlf aggregation may suggest alternate strategies of the inhibition of sickle hemoglobin aggregation.